Cellular and Molecular Imaging Core

Program Director/Principal Investigator (Last, First, Middle): Michael A. Webster
PROJECT SUMMARY/ABSTRACT
Cellular and Molecular Imaging Core
The goal of the Phase III Cellular and Molecular Imaging (CMI) Core is to provide COBRE investigators at the
University of Nevada, Reno (UNR) state-of-the-art imaging tools and training in neuroscience-oriented research.
The Core provides equipment and expertise in two-photon, confocal and wide-field Thunder microscopy with
advanced computational capabilities in the visualization, quantification and interpretation of cells, tissues, whole
organs, and small animals. The Core also provides molecular imaging equipment for the detection, quantification,
and analysis of biomolecular samples such as DNA, RNA, and protein. The Core will assist investigators with
collecting image data and analysis to further their research, facilitate publication and to enhance their
competitiveness for extramural grant funding. The Core equipment is centrally located in the Biology Department,
in close proximity to COBRE investigators, and has successfully developed a wide user base (19 research labs
and counting) with high level of interactions among users. The Core will be directed by Dr. van der Linden, who
developed the core in Phase II. Building on its success during Phase II, the Core will expand and accelerate
research productivity of COBRE investigators and others with the following specific aims: 1) To provide continued
access and technical support to investigators whose research requires the acquisition of high-quality microscopy
and molecular data using our existing and recently added technologies and imaging platforms. The Core will
also leverage a modern renovated Tissue Culture facility supported by the former Cell Biology COBRE center;
2) To provide access, training and education in cellular and molecular imaging research and resources, together
with imaging expertise and experimental assistance needed for image data collection, analysis, and
interpretation. As such, the Core will recruit a new Imaging Specialist to meet the increasing needs of microscopy
imaging; 3) To establish cost-effective services towards a sustainable core facility. In sum, CMI Core resources
and services will create a path for COBRE investigators and others to exploit advanced imaging technologies,
allowing them to take their research into new directions and discoveries with an emphasis on gaining
fundamental knowledge in nervous system function and development, and its associated diseases.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Michael A. Webster PROJECT NARRATIVE Cellular and Molecular Imaging Core Modern neuroscience research requires access to newly emerging technologies and instruments that are often difficult and impractical to support in individual laboratories. Building on its successful operation and support of outstanding investigators at the University of Nevada, Reno (UNR), the COBRE Cellular and Molecular Imaging (CMI) core facility seeks continued funding to transition to a sustainable core to provide support to COBRE faculty investigators and others with an emphasis in gaining fundamental knowledge about the basic function, development and disorders of the nervous system. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page